Brain Capillary Mechanosensation by Piezo1 Channels in Health and Disease

Cerebral blood flow is exquisitely controlled to satisfy neuronal metabolic demands. An essential feature of this control
is the on-demand increase in local blood flow triggered by neural activity; a process termed functional hyperemia (FH)
that is coordinated by multiple neurovascular coupling mechanisms. Importantly, the increases in shear stress in
response to enhanced blood flow constitute mechanical forces with the potential to impact vascular behavior. A
growing body of evidence indicates that hypertension attenuates FH. Notably, uncontrolled elevation of blood
pressure is associated with dramatic alterations in the hemodynamic forces imposed on the vasculature. However, the
extent to which mechanosensitive properties of the cerebral circulation are impacted by hypertension has not been
explored. Piezo1, a Ca2+/Na+-permeable, mechanosensitive channel expressed in vascular endothelial cells, is the
major mechanosensor in brain capillaries. Intriguingly, a gain-of-function mutation in the PIEZO1 gene has been
reported in African Americans populations, which show the highest prevalence of hypertension in the world (>40%).
Based on the unique properties of Piezo1 channels and the essential role of endothelial Ca2+ signaling in FH, I will
evaluate the following hypotheses: (1) brain capillary Piezo1 channel activity is altered during hypertension; and (2)
this change in Piezo1 function is implicated in the deficits in FH that occur during hypertension. These hypotheses will
be tested by directly measuring Piezo1 channel activity and by measuring cerebral blood flow in the context of normal
and high blood pressure. We will use technical innovations introduced by our laboratory that include cutting-edge
genetically engineered mouse models with increased or decreased Piezo1 activity and mice with endothelial-specific
genetically encoded Ca2+ indicators. By viewing hyperemic 'responses' through a new lens as mechanical 'stimuli', the
proposed studies envision normal and perturbed (i.e., hypertension) cerebral blood flow from a completely fresh
perspective. This project has the potential to profoundly alter our understanding of cerebral blood flow dysregulation
during hypertension and may reveal sorely needed new paths to treatment.

Public health relevance
As blood moves through a narrow brain blood vessel, it imposes mechanical forces on the vessel wall, raising the question whether capillaries sense the forces associated with blood flow. We will explore how blood vessels sense disrupted forces during hypertension using engineered mice and advanced imagining techniques to observe brain blood flow. Findings may lead to strategies to prevent deficits in blood flow in human diseases such as hypertension.